Support for Graduate, PDF and New Faculty Presenters at the 2022 American Society of Pharmacognosy Meeting

PROJECT SUMMARY/ABSTRACT
Natural products have provided humankind the key starting materials to support health by providing therapeutic
agents and structural templates for medicinal chemists. The field of natural products is rapidly evolving to fill
anticipated supply gaps due to the movement away from petroleum based energy, fine chemicals and
pharmaceuticals. Although only about 1% of every barrel of oil is used in the manufacture of pharmaceutical
products it is estimated petroleum supplies 99% of the starting materials for pharmaceutical and other consumer
products. Thus one of three key Aims of this meeting includes the replacement of petroleum based starting
materials for therapeutics with natural products. A second key aim for this meeting is an assessment of panomics
approaches to the discovery and development of natural product prototypes for the control of cancer and
emerging infectious diseases, including SARS-CoV2. Emerging methods involving CryoEM in drug discovery
and development will be featured at this meeting. The need for better controls for emerging infectious diseases
needs no explanation; however; the role of natural products as critical starting materials and new prototypes will
be addressed as part of the 2022 American Society of Pharmacognosy Conference. Finally, a third key aim of
the program is to assess the role that natural products and natural products investigators can play in controlling
carbon dioxide levels in the environment. This can take the form of photosynthesis of agriculture or direct
conversion of CO2 into the starting materials for pharmaceuticals and other consumer products. We fully
anticipate that NPs will serve the needs of human health in regard to new prototypes well into the future. This
conference will showcase many aspects of these emerging needs with cutting-edge approaches that are moving
the field forward at an accelerated pace. We have selected leaders in the field as conference chairs and speakers
that align well with the mission of the NCCIH including a significant number of speakers with expertise in
analytical techniques for evaluating and standardizing materials used as complementary medicines. This project
seeks funding to support the American Society of Pharmacognosy (ASP) meeting that will be held July 23-28th
in Charleston, SC. The ASP is the largest society in the USA that focuses on natural products. The ASP as well
as this conference focuses on molecules from nature and their application to improve human health. Support
from the NIH will help offset registration fees and assist with travel for students and new faculty from the US and
US Territories with a focus on regional HBCUs (historically black colleges and universities) of the South Eastern
US. Thus our final aim is to train the next generation of scientists through the recruitment and support attendees
from the PUIs with a focus on the Southeastern US.

Public health relevance
PROJECT NARRATIVE Natural products have historically played a critical role in providing new prototypes for the control of cancer, emerging infectious diseases and neurological disorders and the need for new small molecule, broad-spectrum prototypes could not be more evident from the impact SARS-COV2 has had on global health. The 2022 American Society of Pharmacognosy conference will provide an outstanding venue for education, training, and stimulation of new collaborations in the areas of drug discovery, sustainability and the broader impacts of natural products on human health. This project aims to support registration and partial travel fees for under-represented groups in science including regional HBCUs.